Antibody-based gene-agnostic treatment for inherited retinal degeneration

PROJECT SUMMARY
Retinitis Pigmentosa (RP), or Rod-Cone Dystrophy, is the most common inherited retinal degeneration (IRD)
and represents the leading cause of visual impairment and blindness in individuals under 60 years of age. RP is
associated with mutations in approximately 80 genes that are critical for retinal function, leading to the
progressive primary death of rod photoreceptors, followed by secondary death of cone photoreceptors. With the
human retina containing approximately 100 million individual rod cells, each packed with large amounts of
membrane around individual outer segment discs, rod cell death represents a significant debris burden. Toxic
byproducts from this debris lead to secondary damage of surrounding photoreceptors and underlying retinal
pigment epithelium (RPE), disrupting the cellular communication and mechanisms essential for vision. The
current therapeutic pipeline in RP, however, does not directly address this upstream problem of cytotoxic
photoreceptor debris and thus significant visual improvement may be limited. Moreover, these approaches are
limited to select populations of RP patients that fit a gene specific mutation or represent end stage disease. To
address these significant drawbacks, Piximune Inc. has developed a unique class of therapeutic antibodies to
treat RP in a gene-agnostic and cell type-agnostic manner. Furthermore, these antibodies can be administered
early in the disease process when only rods are dying, or in the intermediate and late phases when cones are
impacted. The mechanism of action centers on augmentation of natural mechanisms that eliminate debris from
dead and dying photoreceptors, thereby ensuring that surrounding functional cells are sufficiently shielded.
Uniquely, this approach offers protection against secondary damage of all photoreceptors (rods and cones) and
RPE cells independent of the causal gene mutation, allowing broad treatment of RP. Piximune Inc. has
demonstrated pharmacological augmentation of this natural mechanism for photoreceptor debris clearance
successfully mitigates secondary damage in photoreceptor degenerative disease models in mice, identifying an
important drug target that is conserved in humans. To date, Piximune Inc. has identified 21-human specific
antibodies, which will be further tested for augmentation, stability and efficacy of retinal cell health and protection
in this Phase I SBIR proposal. This work represents a critical step towards IND-enabling studies and clinical
development.

Public health relevance
PROJECT NARRATIVE Retinitis Pigmentosa (RP) is the most common inherited retinal degenerative disease accounting for 25-30% of visual disability cases in individuals aged 20-60. Despite this burden, therapeutic interventions are limited to a small portion of RP patients and have demonstrated minimal efficacy, representing a critical unmet need in retinal health. Piximune Inc. is developing a novel, immune-based approach for targeted rescue of cell death experienced in a variety of RP patients for visual enhancement and mitigation of disease progression.